Improving Steps in the Development and Assessment of Live Microbiome-Based Products: Fecal Microbiota for Transplantation (FMT) and Live Biotherapeutic Products (LBPs)

This IAA seeks to support the development and assessment of live microbiome-based therapeutic products used for the treatment and prevention of infections and other health conditions.